Administrative Core

ABSTRACT | ADMINISTRATIVE CORE
The Administrative Core (AC) of the Ponce Health Sciences University-Moffitt Cancer Center (PHSU-MCC)
Partnership serves as its central coordinating component. The AC manages all aspects of the Partnership
including day-to-day administrative and financial supervision, recruitment and retention of members,
communications, coordination of activities, logistical support, and charting the Partnership’s present and future
directions. Administration occurs jointly at Ponce Health Sciences University (PHSU) and Moffitt Cancer Center
(MCC) with continuous communication by the AC co-leaders. The AC supports the growth, stability, and
infrastructure of the Partnership and actively recruits and promotes Early-Stage Investigators (ESIs). The AC
has facilitated a significant increase in Partnership research, grant funding, and publications while providing
support and continuity for the Partnership investigators and the communities during multiple major hurricanes,
earthquakes, and the pandemic. The AC leadership has worked closely together for the last 16 years and
possesses a wealth of institutional, Partnership, and NCI knowledge providing long-term stability. The AC will
continue to support all projects, cores, and shared resources and act as the incubator for innovative efforts to
reduce cancer disparities in Hispanic/Latino (H/L) communities. The goals of the AC are to support growth and
innovation, which is accomplished by the following specific aims: 1) Provide infrastructure for the Partnership.
The AC will provide oversight and support related to scientific leadership, fiscal oversight and management,
recruitment and retention of faculty and Partnership staff, productivity oversight, preparation of non-competing
progress reports, and conflict resolution. The AC will accomplish this aim by establishing clear expectations,
setting the overall direction of the Partnership, and developing new leaders to promote its sustainability. 2)
Facilitate communication and integration throughout all levels of the Partnership by ensuring the dissemination
of activities, opportunities, challenges, and accomplishments to all members of the Partnership, Institutional
leadership, and the broader institutional members. 3) Manage and advance the portfolio of Partnership research
projects from initial solicitation through acquiring independent external funding. The AC will stimulate scientific
discussions, set the guidelines and timing of all new project solicitations, and manage the selection and activation
of high-impact projects. The AC will provide support for scientific publications, submission of research grants to
external funding agencies, and identify additional resources for project success. 4) Support the advancement of
Early-Stage Investigator (ESI) careers. The AC will identify and recruit promising ESIs to the Partnership, foster
their development, and oversee their progress collaborating with the Research Education Core (REC) to provide
career development resources, mentoring, and sponsorship tailored to each ESI. The overall goals are to
promote the career advancement of a diverse junior faculty pool and to attract young investigators to focus on
cancer health disparities and minority health.